Mechanisms for initiation of food allergy early in life

PROJECT ABSTRACT
Food allergy often starts early in life and can be life threatening. Early introduction of peanut consumption is
recommended to reduce development of peanut allergy. However, in the LEAP study, 14% of children were not
included because they were skin prick positive for peanut allergy at the start or because they developed reactions
during oral peanut exposures. Peanut allergy is associated with loss-of-function mutations in skin barrier genes.
In mechanistic studies, we demonstrated that neonatal mice with heterozygous skin barrier mutations developed
food allergy by skin co-exposure to detergent, food allergen and a ubiquitous environmental allergen, Alternaria
alternata (Alt) or house dust mite extract. Importantly, the skin sensitizations were performed before any visual
evidence of eczema in the neonates. It is conceivable that for children, skin sensitization with food antigens could
occur before clinical signs of eczema. We demonstrated that oral peanut consumption before skin sensitization
inhibited development of food allergy, but this inhibition was blocked by Alt on the skin during oral peanut
consumption. This may be important for children with skin barrier defects but without early signs of eczema, who
are exposed to ubiquitous environmental allergens while undergoing oral peanut induction of tolerance. In this
proposal, we develop the novel concept that there are skin-derived systemic factors that block tolerance and
that can serve as risk factors for development of food allergy, and that, there are skin-derived factors that may
predict existence of sensitization to food allergy before oral consumption of food allergens. Our preliminary data
from bulk and single cell RNA-seq analyses of sensitized skin from neonatal mice indicate signals that define
unique function of environmental allergen for induction of food allergy and signals that are unique to the
combination of Alt and food allergen exposure of neonates with skin barrier mutations. Our long-term goal is to
identify mechanisms for initiation of food allergy by skin exposures and identify factors for detection of risk for
skin sensitization. As a step towards our long-term goal, our central HYPOTHESIS is that initiation of food allergy
by skin exposure to allergen is mediated by signals from skin with barrier mutations that induce a network of cell
signals for activation of the immune system to generate allergen-specific IgE. We will test our central hypothesis
with the following aims: Aim 1. Test the hypotheses that skin, with barrier mutations, stimulated by food allergens
and environmental allergens produce factors that A) are systemic signals, B) can block oral food antigen-induced
tolerance and C) can mediate susceptibility to development of food allergy. Aim 2. Test the hypothesis that
initiation of food allergy is mediated by recognition molecules expressed by skin with barrier mutations. Aim 3.
Test the hypothesis that allergen stimulates keratinocytes with defects in skin barrier genes (Flg or Tmem79) via
pathways that converge to induce expression of a common set of factors detected in the RNA-seq analysis.

Public health relevance
PROJECT NARRATIVE Our long-term goal is to identify mechanisms for initiation of food allergy by exposures of skin with barrier mutations and to identify factors for detection of risk for skin sensitization. As a step towards our long-term goal, our central HYPOTHESIS is that, early in life, initiation of food allergy by skin exposure to allergen is mediated by signals from keratinocytes with skin barrier mutations that induce a network of cell signals in the skin for activation of the immune system to generate allergen-specific IgE. These mechanistic studies will have a sustained impact in providing a basis towards designing interventions and clinical studies to modify food allergy initiation early in life.